TASK A111: THERAPEUTICS TESTING IN A MURINE MODEL OF MULTIPLE DRUG RESISTANT (MDR) PSEUDOMONAS AERUGINOSA LUNG INFECTION

This contract provides for the development and standardization of small animal models for infectious diseases, and may include efficacy testing of candidate products.